DP21-001 Component A Core Surveillance: Illinois Pregnancy Risk Assessment Monitoring System (PRAMS) project to collect and analyze survey data to improve maternal and infant outcomes 2021-2026

Component A: Core Surveillance
Illinois PRAMS Project Summary/Abstract
The mission of the Illinois Department of Public Health (IDPH) is to protect the health and
wellness of the people of Illinois through the prevention, health promotion, regulation, and
control of disease and injury. The goal of the IDPH Illinois Pregnancy Risk Assessment
Monitoring System (PRAMS) core surveillance project is to reduce infant morbidity and mortality
by improving maternal health through the collection of high-quality data used for research and
data-driven program and policy development that promotes systems changes and adoption of
healthful behaviors before pregnancy, prenatally, and after delivery.
Illinois PRAMS provides the source of statewide epidemiologic surveillance data on the
health and experiences of women with recent live births. Illinois PRAMS collects survey data
following a standardized protocol that produces information on the behaviors and experiences of
women with a recent live birth that is not otherwise available. Illinois PRAMS randomly samples
women from vital records birth files and stratifies the sample to be representative of low
birthweight births. The specific aims are:
• To collect population-based data of high scientific quality on topics relating to pregnancy
and early infancy;
• To conduct data analyses to increase understanding of maternal behaviors and
experiences before and during pregnancy and early infancy and their relationship to
health outcomes;
• To translate results from analyses into useable information for planning and evaluation
of public health programs and policy; and
• To build state capacity for collecting, analyzing, and translating data to address relevant
maternal and infant health issues.
The goal and specific aims of the Illinois PRAMS project help IDPH fulfill its mission. IDPH
has been a funded PRAMS site since 1996.

Public health relevance
Component A: Core Surveillance Illinois PRAMS Project Narrative By monitoring the behaviors and experiences of women before, during, and after pregnancy, the Illinois Pregnancy Risk Assessment Monitoring System (PRAMS) surveillance project provides epidemiologic surveillance that enables analysis of trends, identification of emerging issues, and demonstration of priority need areas. State and local maternal and child health programs, academic partners, and others rely on this information to identify priorities, to plan health programs, and to create policies that improve the health and well-being of women and infants and reduce morbidity and mortality.